Parent-focused primary prevention of child sexual abuse: An Effectiveness-Implementation Hybrid Trial

ABSTRACT
Child sexual abuse (CSA) is a global public health problem affecting 1 in 5 girls and 1 in 12 boys before age
18. Parents are uniquely positioned to protect children from CSA, yet parents have largely been ignored in
CSA primary prevention efforts and the few that do exist have not demonstrated a significant effect on
protective behaviors. Parent education (PE) programs provide parents with foundational skills related to child
development, parent-child communication, and safety. These foundational skills can be logically extended into
didactics relevant to CSA prevention: healthy sexual development, strategies for parents to communicate with
their children and others about sexual topics and sexual behaviors, and creating physical and online
environments safe from potential exploitation and recognizing grooming behaviors. Our team developed Smart
Parents – Safe and Healthy Kids (Smart Parents) as a single session, skills-based, parent-focused CSA
prevention module that adds these key CSA-specific prevention concepts to PE program curricula. Leveraging
the PE foundational skills, Smart Parents provides parents with CSA-prevention knowledge to increase their
CSA-related attitudes and perceived norms as well as the opportunity to practice protective behavioral skills. A
recent cluster randomized clinical trial demonstrated preliminary to be effective in raising parents' awareness
and increasing their intention to use of CSA protective behaviors when added to Parents as Teachers (PAT),
an evidence-based PE program supported by most state child welfare systems. The proposed study seeks to
expand the empirical evidence for the effectiveness of Smart Parents and to explore the implementation
factors that might promote or hinder adoption, fidelity, and scalability, the proposed study uses a type 2 hybrid
effectiveness-implementation design. We will conduct a stepped wedge-cluster randomized trial (N = 400) To
determine effectiveness (Aim1) of Smart Parents when added to PAT (PAT+Smart Parents) on CSA-related
awareness and intention to use CSA protective behaviors compared to parents receiving PAT treatment as
usual (PAT-TAU. We will follow-up participating parents in both conditions at 12- and 24-months to determine
retention of awareness (i.e., knowledge and attitudes) and actual use of protective behaviors (Aim 2). To
describe factors that hold promise for future dissemination and implementation efforts (Aim 3), we will: assess
parent, provider, and organizational-level moderators of Smart Parents effectiveness; conduct a cost analysis;
and conduct structured interviews with Smart Parents providers (N = 100) and focus groups with key PE
stakeholders (N = 25) to identify factors that may impact future dissemination and implementation. By
leveraging the foundational skills taught in existing PE used by state-supported family service providers across
the US—and supported through federal policy such as the Family First Prevention Services Act—the
integration of Smart Parents into PE programs is not only efficient and cost-effective, but constitutes a
sustainable model of system-wide, real-world, community-based implementation of primary CSA prevention.

Public health relevance
PROJECT NARRATIVE Equipping parents with skills-based strategies to protect children will fill a large gap in primary child sexual abuse (CSA) prevention efforts. Smart Parents – Safe and Healthy Kids (Smart Parents) is a parent-focused, CSA-specific, skills-based module that can be added in a single session to evidence-based parent education (PE) programs used by state-supported parent service agencies across the U.S., including Parents as Teachers. Moreover, by leveraging existing PE implementation infrastructures well-supported by federal funds (i.e., Family First Prevention Services Act), the sustainability and scalability of Smart Parents is greatly enhanced, thereby maximizing the potential for public health impact and a move toward the reduction of rates of CSA.